Motivational Refinements for Facilitating Reinforcement Schedule Thinning

Project Summary
Severe destructive behavior represents a comorbid condition of developmental disability for which risk
increases with intellectual disability severity, communication deficits, and co-occurring autism spectrum
disorder.1,2 Destructive behavior, such as self-injurious behavior and aggression, causes harm to the child and
others and increases the risk for institutionalization, social isolation, physical restraint, medication overuse,
service denial, and abuse.3 Clinicians have used functional analyses to identify the variables that reinforce
destructive behavior and to develop effective, function-based treatments.4-7 Functional communication training
(FCT) is an empirically supported, function-based treatment that decreases destructive behavior.8,9 Using FCT,
the clinician teaches the child to use a functional communication response (FCR) to request the reinforcer
maintaining destructive behavior, while placing destructive behavior on extinction.10-12 For example, if
functional-analysis results showed that attention reinforced destructive behavior, the clinician would provide
attention when the child used the FCR (“Play with me, please”) and would not provide attention for destructive
behavior. Two important limitations of FCT are that (a) schedules of reinforcement maintaining the FCR must
often be thinned gradually to levels that are practical for caregivers to implement consistently in the home and
in the community,13-15 and (b) this necessary process of reinforcement schedule thinning regularly causes
destructive behavior to increase following initially effective treatment, a form of treatment relapse called
resurgence.16-19 The current project aims to improve these limitations of FCT by (a) hastening the process of
reinforcement schedule thinning by removing unnecessary schedule-thinning steps using the results of a
progressive interval assessment20-23 and (b) mitigating the resurgence of destructive behavior by providing
stimuli that highly compete with the reinforcer maintaining destructive behavior.23-27 We will conduct a
randomized controlled trial to evaluate the extent to which these two promising refinements to FCT improve the
process of reinforcement schedule thinning, and an exploratory study will examine the interactive effects of
these two approaches. This novel project has the potential to substantially improve standards of care guiding
the treatment of severe destructive behavior and to improve the long-term outcomes for children and families
afflicted by these debilitating behavior disorders.

Public health relevance
Project Narrative This project aims to improve the treatment of severe destructive behavior exhibited by children with developmental disabilities by refining the critically important process of reinforcement schedule thinning. Reinforcement schedule thinning will be completed in fewer sessions when its starting point is informed by the results of a progressive interval assessment, and providing competing stimuli will further shorten this process by producing less destructive behavior when compared to a traditional treatment. These treatment gains will extend to a condition in which the reinforcer for destructive behavior remains unavailable for an extended period of time.